PFAS sensor for remediation and industrial wastewater treatment optimization applications

Project Summary/Abstract
The goal of this project is to develop a sensor for monitoring of per- and polyfluoroalkyl substances (PFAS) in
water for remediation applications. PFAS have received particular attention in the past decade due to their
persistent and bio-accumulative nature and high toxicity. The proposed sensor is based on infrared (IR)
spectroscopy that incorporates advanced membrane materials coated on surfaces of infrared waveguides for
trapping of contaminants to achieve high selectivity and sensitivity. The proposed technology can be adapted for
portable, automatable, and cost-effective screening of water in field conditions and for in-line water quality
monitoring in water treatment trains. The

Public health relevance
Project Narrative Per- and polyfluoroalkyl substances (PFAS) are contaminants of emerging concern due to their persistent and bioaccumulative nature and high toxicity to human health and the ecosystem. PFAS sensors are essential in remediation applications to accurately detect and monitor the presence of these persistent contaminants. The public health relevance of the proposed sensor technology is its potential for real-time water quality monitoring in order to limit human exposure and environmental contamination.